Non-Coding RNA Analytical Core

Summary
The purpose of this program is to significantly advance our understanding of mechanisms of HDL Dysfunction
in Projects (1) familial hypercholesterolemia (2) chronic kidney disease, (3) small RNAs, and (4) reactive
dicarbonyl modification to HDL. The proposed research strategies are highly cross-disciplinary and require
extensive next-generation RNA sequencing, data analysis, and data integration. An effective and dedicated non-
coding RNA and bioinformatics core is essential for the success of the proposed studies in each project and the
overall program. Specifically, the Non-Coding RNA and Bioinformatics Core is designed to handle the large
volume of sequencing needs and data analyses for all 4 projects. We are highly trained, skilled, and experienced
in generating sRNA-seq libraries, bulk total RNA-seq libraries, and 10X Chromium single cell RNA sequencing
(scRNA-seq) preparations for high-throughput sequencing. We are proficient in performing quality control steps
and completing the sequencing tasks. Furthermore, we have developed in-house sequencing analysis pipelines
that will be implemented by computational biologists and biostatisticians under the guidance of an existing
informatics team that has worked closely over the past 6 years. The purpose of the Non-Coding RNA and
Bioinformatics Core is to use high-throughput RNA sequencing and informatics to analyze small and long RNA
expression changes associated with HDL dysfunction and atherosclerosis treatments in a timely and efficiently
manner with high-quality data management and integration into complex bioinformatics systems.